SUBJECT MATTER EXPERT CONSULTANT FOR DRUG METABOLISM PHARMACOKINETICS [DMPK].

Drug Metabolism Pharmacokinetics

The Contractor shall provide consulting support services to the NIH Blueprint Neurotherapeutics Network as
follows:
• Evaluate pharmacokinetics study protocols and data to identify potential drug discovery and development
challenges. Recommend strategies to address these challenges.
• Develop plans to assist NIH BPN staff in strategically managing pharmacokinetic programs which facilitate assay
development, exploratory chemistry, lead optimization, formulation activities, investigational new drug (IND)
enabling, and clinical studies.
• Assist NIH BPN staff to design investigative pharmacokinetics studies, including study strategy and experimental
design. Provide advice regarding recommended study milestones and prepare milestone reports are needed.
• Facilitate Lead Development Team discussions via telephone and email regarding assigned drug metabolism
and pharmacokinetics efforts.
• Analyze and interpret data for pharmacokinetics drug discovery, development, and translational projects.

Public health relevance
Subject matter expert support for developing therapies for neurological disorders